Fort Belknap - JHU NARCH XI

PROJECT SUMMARY
The Aaniiih and Nakoda Tribes of the Fort Belknap Reservation have established a trusting research
partnership with the Johns Hopkins School of Nursing and look forward to the expansion of this partnership
through the NARCH XI proposal. This proposal will allow us to work toward a future in which health disparities
are eliminated on the Fort Belknap Reservation. The overall goals of the NARCH XI proposal are threefold: (1)
train Aaniiih and Nakoda NARCH scholars to reduce health disparities and promote wellness through
academic opportunities, public health and research training, and research field experiences; (2) build research
capacity through two community-based research projects to address priority health concerns; and (3) build
factors which promote resiliency across all NARCH trainings and interventions. We will address these aims
through three projects: (1) the Aaniiih and Nakoda Student, Tribal Health Leader, Faculty, and Nurse Training
Program, which will advance research and behavioral health provider capacity while developing a pathway for
success of future Aaniiih and Nakoda nurses, researchers, and healthcare providers at Fort Belknap; (2)
Improving Suicide and Suicide Cluster Prevention in High-Risk Remote Reservation Settings research project;
and (3) Adapt and evaluate an evidence- and technology-based safety planning intervention, myPlan app, to
improve the safety and health of Native American adolescents in rural settings research project. The research
projects will provide applied training opportunities for Aaniiih and Nakoda NARCH scholars from high school, to
graduate, and to tribal health leaders. The projects have been designed to facilitate collaboration and learning
across projects, with the goal of increasing research and training capacity, understanding risks and protective
factors against suicide, and helping our youth establish safe, healthy relationships. These research projects
were determined based on Fort Belknap Tribal Council priorities and through the input of community
stakeholders. Two Tribal Advisory Boards (TAB) will guide and oversee all projects over the course of the
projects. Community-based participatory research methods will be utilized for all projects; our team believes
that community leadership is essential to the success of the proposed projects and continued development and
sustainability of research and training in the Fort Belknap Community.

Public health relevance
PROJECT NARRATIVE: The Fort Belknap Community (FBC)-Johns Hopkins School of Nursing (JHU) NARCH XI programs will build individual and tribal capacity to address health disparities and promote wellness on the Fort Belknap Reservation through research and training. Aaniiih and Nakoda students, faculty members, tribal health leaders, and nurses will complete training in STEM, public health, and nursing, and engage in the adaptation and evaluation of the JHSON Mental Health Training program. Additionally, they will participate in hands-on community-based research training through the two research studies to: (1) reduce risk and promote healing after a suicide death and to develop a suicide cluster response plan, and (2) adapt the myPlan app to improve safety and health of adolescents.